Contributions of autophagy-related genes in lupus

ABSTRACT
Lupus or systemic lupus erythematosus (SLE) is a potentially fatal autoimmune disease with a substantial
genetic basis. SLE is characterized by abnormal T- and B-cell responses, production of numerous pathogenic
autoantibodies, and immune complex deposition, leading to various clinical manifestations including multi-organ
damage (e.g., kidneys, skin). SLE has disproportionate impacts based on gender and ethnicity. Approximately
90% of those affected are women. In addition, SLE has a 3-5-fold higher prevalence in Asian, African-American,
and Hispanic individuals compared to those with European ancestry, as well as more severe clinical manifesta-
tions, including organ damage (e.g., nephritis). Evidence from genetics, cell biology, and animal models suggests
that autophagy, a major pathway for organelle and protein turnover, plays a pivotal role in SLE pathogenesis.
Autophagy is a highly conserved lysosome-mediated catabolic process that removes unwanted cytoplasmic
components (e.g., long-lived and/or misfolded proteins) and damaged organelles. This process maintains cellular
homeostasis and survival under metabolic stress. Recent genome-wide association studies (GWAS) have linked
autoimmune diseases, including SLE, to autophagy-related genes. However, there is currently a huge gap in
defining causal relationships between associated variants and molecular mechanisms underlying SLE. This lack
of knowledge about pathogenic effects underlying GWAS signals hinders translating GWAS discoveries into
diagnosis and treatment. To address this issue, we selected six highly ranked, well-replicated loci; four of them
were initially discovered in Asian populations, two we previously reported as novel loci for SLE susceptibility. We
have assembled a research team with the expertise and resources to discover and mechanistically characterize
functional variants linked to SLE. We hypothesize that at each GWAS locus, both common and rare variants
contribute to SLE risk by affecting expression of autophagy genes through tissue-specific regulatory elements.
Aim 1 will identify SLE-predisposing variants using a comprehensive imputation-based analysis of combined
novel resequencing data from SLE patients and controls in addition to our previous fine-mapping of four ethnically
diverse populations. Functional variants will be prioritized by allele-specific expression, open chromatin, and 3D
interaction data from immune cells. We will elucidate genetic and clinical heterogeneity of SLE by assessing
association of identified variants with SLE and its clinical manifestations and autoantibody profiles. Associated
variants, especially imputed and rare variants, will be validated through follow-up genotyping. Aim 2 will define
the mechanistic and functional consequences of SLE-predisposing variants using appropriate functional assays,
including CRISPR-based gene knock-out and base-editing in cell lines (Jurkat, Toledo, podocyte, HEK293) and
primary immune cells (T- and B-cells) relevant to SLE. Thus, we will uncover functional variants underlying SLE
association signals, and illuminate mechanisms by which these variants contribute to lupus and its clinical
manifestations. Through this approach, our analysis should yield novel targets for potential clinical interventions.

Public health relevance
PROJECT NARRATIVE Lupus is a chronic, multisystem, autoimmune disease with profound associated morbidity and early mortality that disproportionally affects women and certain ethnic populations (e.g., Asian). Lupus has a substantial genetic component, and recent studies on lupus and other autoimmune diseases have linked several single nucleotide polymorphisms (SNPs) with autophagy-related genes, suggesting their role in lupus and general autoimmunity. This project will identify and map the most likely SLE-predisposing variants at six autophagy-related loci discovered in Asian populations, determine their functional roles, and uncover the molecular mechanisms that contribute to SLE pathogenesis across multiple ethnicities.